Estrogen receptor reprogramming ligands for the prevention of protracted menopausal symptoms and chronic diseases

Project Summary/Abstract
Because of longer lifespans, health problems affecting menopausal women are becoming increasingly common.
Hot flashes, sleep issues, and mood swings are typical short-term symptoms that can have a negative impact
on quality of life and productivity at work. An increased incidence of chronic disorders such as osteoporosis,
obesity, diabetes, metabolic syndrome, and cardiovascular disease is linked to long-term estrogen insufficiency
following menopause. Menopausal hormone therapy (MHT) is effective at reducing menopausal symptoms and
preventing some chronic diseases, but according to the Women's Health Initiative (WHI), long-term therapy has
more risks than benefits. The use of MHT among menopausal women has sharply dropped since the publication
of the WHI data. MHT is currently recommended for a 5-year short-term treatment of hot flashes and vaginal
symptoms. MHT is no longer recommended for the primary prevention of chronic diseases. Countless
menopausal women continue to wait anxiously for a safer long-term MHT to improve their quality of life and
health. In the meantime, many women opt for unproven supplements to relieve menopausal symptoms. There
is a significant unmet need for developing new MHT formulations that can be utilized for long-term therapy
because many women suffer from menopausal symptoms for more than five years and chronic diseases increase
throughout menopause. Almost 80 years after MHT was approved, there is still no MHT formula safe for long-
term therapy. Our objective is to develop a safer MHT formula that can be used long-term to treat protracted
menopausal symptoms and prevent chronic diseases, such as osteoporosis, diabetes, obesity, and metabolic
syndrome. We discovered a class of compounds that we termed estrogen receptor (ER) reprogramming ligands.
We found that when a reprogramming ligand is combined with estradiol (E2), a new set of genes are regulated
that are not regulated by the reprogramming ligand or E2 alone. The reprogramming ligand blocked the
proliferation of human breast cancer cells and the growth of the mouse uterus in response to E2. Our goal is to
create an E2/reprogramming ligand combination by replacing the progestin component of MHT with a
reprogramming ligand and adding it to the estrogen-alone formulation. Our hypothesis is that the
E2/reprogramming ligand combination will be safer than the single estrogen and estrogen/progestin MHT
preparations currently on the market so that they can be used as a long-term therapy to prevent protracted
menopausal symptoms and chronic diseases. Our original reprogramming ligand was a natural compound. To
improve its pharmacological properties and strengthen its patent protection, we prepared and identified several
synthetic analogs that behave similarly to the natural reprogramming ligand in cell-based assays. As the next
step in the clinical development pathway, we will test the synthetic analogs in animal models to select the lead
analog that is the most effective and safe for future clinical trials.

Public health relevance
Project Narrative Menopausal hormone treatment (MHT), which contains estrogen, can relieve hot flashes and help menopausal women avoid some chronic illnesses like osteoporosis. The current MHT regimens are not recommended for long-term use due to the potential for serious adverse effects. Our goal is to develop a long-term MHT regimen that is less harmful and can be used to treat persistent menopausal symptoms and prevent chronic diseases associated with menopause.